ASSESSING THE RISK OF VIOLENCE IN MENTAL PATIENTS

The purpose of the proposed project is to identify the relative contribution of situational stressors, support, and structure as moderators of violent behavior in specific ecological settings: peer, work, family, and treatment. Based on a reciprocal causality model and analysis from prior research, a prospective design with repeated measures and a cross-validation procedure will be utilized to answer specific research questions regarding situational predictors of violent outcome. A total of 1056 adult males presenting at the Western Missouri Mental Health Facility (WMMHF) will be interviewed to obtain predictor measures (Violence Proneness Index; Ecological Participation Patterns; stress, structure, and support in specific settings) and will be categorized into a potentially violent group (744) and a non-violent control group (312). For subjects in the potentially violent group, post-release follow-up interviews will be conducted at three six-month intervals. Violent/non- violent outcome after release will be measured by an arrest or admission for violence or self-reported violence during these three consecutive follow-up periods. Potentially violent subjects will be divided into a calibration and cross-validation sample. Structural equation models will be used to test the proposed model in the calibration sample and the final model in the cross-validation sample. The anticipated final product is a violence risk scale that will include critical situational factors as well as individual proneness; the investigators suggest that such a scale will be useful in treatment delivery settings as a basis for decision-making with respect to treatment, release, follow-up, and case management plans.